IGF::OT::IGF SBIR TOPIC 342 - DIRECT TO PHASE II: A WEARABLE SYSTEM FOR ASSESSMENT OF FALL RISK ASSOCIATED WITH CANCER TREATMENT

The purpose of this Direct to Phase II SBIR project is to develop and prepare the product, Mobility Clinic, for a commercial launch to meet the need of allowing providers to easily quantify balance and gait in the oncology setting. The objective of developing this product is to improve quality access and reduce cost or burden of screening, treatment, and follow-up care for cancer and associated chronic disease; and to improve lifestyle intervention efficacy and stability for cancer related risk factors.